NIDA International Virtual Collaboratory

Support for creation of a NIDA International Virtual Collaboratory to complement research and networking activities conducted through NIDA International Program Office. This product will promote interactions among grantees and their associates and help them build collaboratories.